Cancer Trials Support Unit

The Cancer Trials Support Unit (CTSU) complements many of the NCI-supported clinical trial organizations/programs by providing standardized, centralized, and cost effective administrative, regulatory, logistical, and information technology support. The CTSU provides a wide-variety of operational, administrative, regulatory and logistical support services to NCI multi-center coordinating centers and participating sites.